Utilizing a Lupus Clinical Trials Network to Advance Diversity and Representation in Clinical Trials: Perspectives, Preferences, and Unmet Needs of Patients, Providers, and Stakeholder Agencies

Title: Utilizing a Lupus Clinical Trials Network to Advance Diversity and Representation in Clinical Trials:
Perspectives, Preferences, and Unmet Needs of Patients, Providers, and Stakeholder Agencies
Project Abstract
Despite greater prevalence of systemic lupus erythematosus (SLE) among racial and ethnic minorities, marked
gaps exist between patients affected by the disease and those represented in lupus clinical trials. Advancing
enrollment of underrepresented populations is critical to ensure safety, efficacy, and equity in the process and
products from clinical trials leading to the development of novel lupus therapeutics. However, few studies have
explored the unique perspectives of patients and other key stakeholder groups to identify facilitators and
tangible solutions to increase representation of diverse racial and ethnic participants, particularly in the context
of lupus clinical trials. The goal of this proposal is to advance equity in lupus clinical trials by: a) leveraging
novel data sources to advance evidence for enrollment of underrepresented populations in clinical trials, b)
increasing understanding of diverse voices of key stakeholders in order to identify barriers, facilitators, and
tangible solutions, and c) developing patient-centered clinical trial communication strategies and skills training
for clinicians to improve participant diversity in lupus clinical trials. We will utilize a knowledge translation
framework and mixed-methods approach in order to identify, exchange, synthesize, and disseminate insights
to advance diversity in lupus clinical trials. We will leverage partnerships with the largest lupus clinical trials
network in North America, the Lupus Clinical Investigators Network (LuCIN), and collaboration with key
stakeholder groups to accomplish the proposed aims. The first specific aim of this project is to leverage
existing data to establish a multivariable dataset of participant- and site-level characteristics within the lupus
clinical trials network. The second specific aim is to describe the perspectives, preferences, and unmet needs
of diverse stakeholder groups to improve participation of underrepresented groups in Phase II and III lupus
clinical trials. Discussions will explore stakeholders’ perspectives on the barriers, facilitators, and tangible
solutions at the individual, interpersonal, organizational, and systems-level to improve representation in lupus
clinical trials; and assess stakeholders’ preferences for a practical patient-centered communication toolkit for
clinicians to integrate clinical trial discussions into clinical care. The third aim is to synthesize practical
approaches and resources to improve diversity and representation in lupus clinical trials. Using findings from
Aim 2, we will present a white paper summary outlining a framework of practical solutions to improve
representation in lupus clinical trials. As a tangible next step, we will develop a mockup of an online toolkit for
clinicians that incorporates theoretically-based and evidence-informed approaches to improve patient-centered
clinical trials communication. We will convene a final public roundtable meeting for stakeholders to vet the
white paper findings and online toolkit mockup. We aspire to develop and disseminate a framework of tangible
stakeholder-informed solutions to improve lupus clinical trial diversity; and identify steps to refine the
communications skills toolkit mockup informed by diverse stakeholders in future research.

Public health relevance
Project Narrative There is an urgent need to improve the participation of racially and ethnically diverse participants in lupus clinical trials to ensure that the products from clinical trials are safe and effective for all patients. Thus, it is necessary to explore and address multiple barriers and facilitators to improve diversity and representation in lupus clinical trials. This research project will enhance understanding of the landscape of representation of racially and ethnically diverse participants in lupus clinical trials and lead to the development of a solutions- focused framework to improve representation in lupus clinical trials to ultimately improve patient- and public health outcomes.